Perceptual Effects of Odorant Antagonists

Summary/Abstract
Dr. McClintock’s research on the function of receptors responsive to odors uses a technology that
simultaneously measures the responses of all 1,100 odorant receptors (ORs) and all 14 trace-amine
associated receptors (TAARs) to odors in freely behaving mice, capturing the receptor response patterns that
encode odors. These patterns, often called combinatorial codes, are responsible for odor identification and
discrimination. This technology quantifies both response and loss of response from ORs and TAARs so a
major theme of these studies is investigating the role of odorant interactions in shaping response patterns.
These interactions are common, and because odors are nearly always mixtures of many different odorants,
these findings predict that odorant interactions are fundamental to the encoding and perception of odors in
mammals. Whether these interactions at receptors correctly predict perceptual effects, especially in humans, is
as yet unknown so studies of perceptual effects represent a way to assess mechanistic commonality with
humans. Investigating how these interactions affect odor perception is generally important for understanding
neural coding and antagonist interactions are valuable tools for future studies of odor signal processing in the
brain. In addition, odorant interactions also have translational potential. Prime examples are blocking
perception of malodors that have negative impacts on human health and quality of life. These translational
opportunities motivate work on the development of pharmacological tools to modify responses from specific
ORs and TAARs and thereby manipulate the perception of certain odors. Training in human olfactory
psychophysics proposed in this application will put Dr. McClintock in position to leverage his preclinical data on
odorant interactions into tests of whether these interactions are mechanisms shared with humans and whether
certain odorant interactions have translational utility in humans.

Public health relevance
PROJECT NARRATIVE Recent advances in preclinical studies of receptors directly responsive to odors have opened avenues for producing new ways to understand odorant interactions in humans and ways to block odors that have negative effects on human health and quality of life, such as cigarette odors that increase cravings to smoke, fecal odors that decrease use of latrines, and body odors that affect social interactions. To facilitate translation of his work on volatile molecules that block such odors, Dr. McClintock will learn methods used in human olfactory psychophysics. This training will allow him to determine which odor blockers act similarly from rodents to humans and whether they are promising tools for modifying the perception of odors that negatively impact human health.